Engineering diverse commensal skin bacteria for targeted immunotherapy

PROJECT SUMMARY:
Immune modulation is central to cancer therapy. A major challenge in the field is to develop an effective platform
for stimulating potent, tumor-specific T cell immunity, which selectively destroys cancer cells but leaves healthy
tissue intact. To address this challenge, we propose a novel cancer vaccination platform that uses engineered
skin commensal bacteria to stimulate tumor-specific T cells.
Our central hypothesis is that commensal stimulation of T cells is potent without toxicity, easily directable to our
antigens of choice, and more precisely controls the functional subset of T cells generated. Our rationale is based
upon our previous study, where we discovered a way to leverage Staphylococcus epidermidis (S. epi), a
prevalent commensal skin bacterium that naturally stimulates CD8+ T cells upon colonization. In multiple murine
cancer models, skin colonization by tumor antigen-expressing S. epi expanded tumor-specific T cells, which
protected mice from both local and metastatic cancer and could synergize with immune checkpoint blockade
without autoimmune sequelae. Critically, this work revealed that the immune response to a skin colonist can
promote cellular immunity at a distal site. Further, it highlights the feasibility of redirecting this response against
a therapeutic target of interest by expressing a target-derived antigen in a commensal bacterium.
We now propose to expand our approach of commensal-based cancer immunotherapy. We will leverage
innovative synthetic microbiology principles to overcome the barrier to progress of genetic intractability in a set
of clinically relevant skin commensals. This will enable us to accomplish three major objectives: 1) express
defined tumor antigens in a diverse set of skin commensals, 2) subsequently determine their in vivo T cell
stimulatory capabilities by using our existing workflow, and 3) engineer the most stimulatory commensals into a
potent anti-cancer T cell vaccine, for testing within multiple models of subcutaneous and metastatic cancer.
Thus, will answer fundamental questions about commensal immunity and identify new skin commensal bacteria
that induce CD8+ T cells, increasing the available “vehicles” for commensal-based therapeutics. The tools
developed will also be useful for screening antigen-specific T cell stimulation by undomesticated bacteria from
all body sites. Upon successful completion of this proposal, we will have generated a novel vaccination platform
for cancer using engineered live commensal skin bacteria.

Public health relevance
PROJECT NARRATIVE Current cancer vaccines do not capture the full potential of immune function, leading to limited success in tumor immunotherapy. Recently, we demonstrated that it was feasible to redirect the T cell stimulating ability of Staphylococcus epidermidis, a prevalent commensal skin bacterium, towards a therapeutic target of interest by recombinant surface display of a target-derived antigen, which elicited potent tumor-specific CD4+ and CD8+ T cells that treated both local and metastatic solid tumors in animal models. Here, we will apply novel genetic approaches to engineer antigens into a diverse and representative set of skin commensals, define their T cell stimulating capabilities, and develop the most stimulatory strains as potent, targeted anti-cancer T cell vaccines.